RECOMBINANT METHIONYL HUMAN BRAIN-DERIVED NEUROTROPHON IN ALS PATIENTS

This study proposes to monitor the effect of the BDNF, a known neurotrophic factor, in the rate of neuron degeneration in human als patients.